Administrative Core: An Integrated Multi PI And Multi Site Management Plan For Enhanced Echinobase

SUMMARY ADMINISTRATIVE CORE
An Integrated Multi PI And Multi Site Management Plan For Enhanced Echinobase
The Administrative Core is part of a multi-component plan for the maintenance and enhancement of
Echinobase. The Admin Core is a multi-PI, multi-site management plan that allows for a very cost effective
management of human and other resources, to set priorities and to ensure that milestones are met in a timely
manner. The coordination of efforts from the three PIs, Hinman (CMU), Ettensohn (CMU), and Vize (Calgary)
brings complementary expertise to best achieve the goals of the project. External oversight and expertise is
provided by an established Scientific Advisory Board (SAB); the members are: Ina Arnone (Echinoderm
GRNs, Stazione Zoologica, Italy), Katherine Buckley (Immunology, Auburn University), Andy Cameron
(Echinoderm GRNs, Caltech), Greg Cary (mouse genomics, Jackson Labs), Jose García-Arrarás (regeneration
and neurobiology, University of Puerto Rico), Amro Hamdoun (membrane protein function; Scripps Institution of
Oceanography), Nipam Patel (Director of the Marine Biological Laboratory, University of Chicago), Yi-Hsien Su
(genomic evolution, Academia Sinica, Taiwan). The three PIs will manage the scientific goals of their
respective components. Additionally the Admin Team of PI Hinman and Project Manager Telmer will schedule
meetings between subsets of PIs, all PIs, the Scientific Advisory Board, and with the echinoderm research
community PIs. This will ensure coordination of all subgoals in effectively meeting the overall goals for
Enhanced Echinobase.